LUPRON TEST IN CHILDREN WITH PUBERTAL DISORDERS

The specific aims are to determine whether the hormonal responses to leuprolide acetate (Lupron) will distinguish among the causes of hypogonadism in pre-teen children with hypogonadism, among the causes of precocious puberty, and among the causes of inappropriate puberty. In the latter regard, girls with be compared to adult women with polycystic ovary syndrome to determine whether they have similar ovarian dysfunction, and boys with gynecomastia will be evaluated to test the hypothesis that gynecomastia occurs in boys who produce higher levels of estradiol relative to testosterone than normal. (This is an investigator-initiated study using the probe brandname Lupron)